Cellular Systems Genetic Approaches to Understanding Regulatory Variation

PROJECT SUMMARY/ABSTRACT
The overarching goal of my laboratory is to determine how natural genetic variation influences
chromatin biology, and, ultimately, phenotypic diversity. Most disease-associated variants identified in
human studies occur in regulatory elements rather than in the coding region of genes, highlighting the
importance of understanding the role of regulatory variation in normal health and disease. Gene transcription is
controlled by the interplay between cis-acting regulatory elements and the trans-acting factors that bind them.
Variation within a regulatory element can influence function locally through disruption of a DNA-binding site
targeted by a trans-acting factor at that site, whereas variation in sequence or expression of a trans-acting
factor can result in functional variation distally at many regulatory elements. Regulatory elements are identified
by epigenetic features catalyzed by a variety of chromatin writers. While we have substantial information on the
enzymes that write and erase epigenetic modifications, less is known about the trans-acting mechanisms that
regulate the locations and levels of these modifications, remaining a defining challenge within the field. To
move the field forward, we have developed a novel cellular systems genetics approach that integrates
quantitative experimental techniques and computational methods in statistical genetics to create a
comprehensive understanding of regulatory variation and uncover broadly applicable mechanisms that control
the epigenetic landscape. We will utilize the natural genetic variation intrinsic in a unique panel of mouse
embryonic stem cells that will enable us to harness genetic diversity to identify key chromatin regulators, define
their molecular functionality across multiple phenotypes, and delineate changes in regulatory variation over
developmental time. This mammalian genetic reference panel will greatly improve statistical power to efficiently
map functional loci directly relatable to humans, whereas a cellular platform will enable the identification of their
associated genes and mechanisms of control. Using this system we have discovered multiple genomic
locations that distally control hundreds of regulatory elements and alter gene expression. Our goals in the next
five years are to answer the following questions: What are the molecules and mechanisms underlying trans
regulation of the chromatin landscape? How does genetic variation influence chromatin structure and function?
How does the early establishment of the chromatin landscape impact development? Success of this project will
delineate the interplay between regulatory elements, the systems that control them, and the epigenetic
landscape that defines them. These efforts are expected to have broad implications in both our basic
understanding of chromatin and epigenetic regulation during early development as well as on our ability to
directly tailor in vitro cellular differentiation to genetic background, ultimately impacting developmental biology,
regenerative biology and personalized medicine.

Public health relevance
RELEVANCE TO PUBLICH HEALTH Individual variation in the expression of genes is dependent on the dynamics of how our genetic material is packaged and modified, and plays a major role in disease susceptibility, but we currently know little about the regulatory processes that govern these systems. In this proposal we will quickly and efficiently define the pathways and mechanisms that modulate regulatory variation and function during early mammalian development by leveraging natural variation intrinsic in a unique mouse embryonic stem cell system. By understanding how regulatory variation guides cell fate determination, the outcome of this research will provide fundamental knowledge and offer a contemporary foundation for our understanding of the development of complex traits and guide regenerative medicine.